Project 1: Overcoming therapeutic resistance in pancreatic cancer through epigenetic reprogramming

PROJECT SUMMARY – Project 1: Epigenetics
Pancreatic ductal adenocarcinoma (PDA) is a devastating disease with a disturbing rise in incidence. The poor
prognosis of PDA is attributed, in large part, to inherent resistance to conventional chemo- and immuno-
therapies. Multifactorial contributions from tumor intrinsic and extrinsic epigenomic programs, an elaborate
network of cell-cell communications within the tumor microenvironment (TME), and complex metabolic
adaptations compound to make PDA refractory to the current arsenal of therapies. Proposed experiments use
both pharmacological and genetic targeting of Class I histone deacetylases (HDACs) to determine the
contributions of epigenetically encoded programs to therapeutic resistance. Aim 1 expands on the lab’s finding
that HDAC inhibition (HDACi) leads to a downregulation of DNA damage response pathway genes. The ability
of HDACi to sensitize both organoid and mouse models of PDA to DNA damaging agents is tested by employing
a nanoparticle delivery system that circumvents systemic HDAC inhibitor toxicities in vivo. Given preliminary
evidence that HDACi upregulates autophagy, a known mediator of therapeutic resistance, the ability of
autophagy inhibition to potentiate responses to HDACi (and combinations with DNA damaging agents) is tested
in collaboration with Project 3. Moreover, interrogation of a human organoid bank will delineate how different
mutational profiles impact sensitivities to HDACi and DNA damage. Aim 2 delineates the contribution of HDAC-
regulated epigenetic programs in cancer-associated fibroblasts (CAFs), a heterogenous cell type within the TME,
to PDA outcomes. Preliminary data identifies HDAC1 as the primary HDAC underlying CAF responses to
pharmacological HDACi in vitro. Here, a genetic approach is taken to determine how HDAC1 loss in fibroblasts
impacts CAF functional heterogeneity, tumor growth, and chemoresistance in vivo. Collaborative efforts with
Project 2 elucidate how HDACi influences stromal support of tumor growth and chemoresistance through
alterations in CAF-derived soluble factors, including LIF. In addition, the molecular mechanisms by which HDACi
rewires the epigenome in specific CAF subpopulations is delineated. Lastly, Aim 3 builds on preliminary findings
that HDACi sensitizes PDA mouse models to immune checkpoint inhibition (ICI). In collaboration with Project 3,
the ability of HDACi and autophagy blockade to synergize in promoting ICI responses through convergent
regulation of MHC-I is tested. The possibility of enhancing anti-tumor immunity by inducing immunological cell
death through the combination of HDACi and DNA damaging agents is also explored. In collaboration with
Project 2, how STAT signaling in inflammatory CAF populations influences anti-tumor immunity elicited by
HDACi and ICI is defined. Finally, to determine how HDACi reprograms immunomodulatory features in human
PDA, biopsies from a completed clinical trial combining HDACi and anti-PD-1 ICI are analyzed via digital spatial
profiling. Together, these studies provide critical insight into the epigenetic mechanisms underlying therapeutic
resistance in PDA and explore novel treatment strategies with the potential to improve patient outcomes.

Public health relevance
PROJECT NARRATIVE – Project 1: Epigenetics Pancreatic ductal adenocarcinoma (PDA) is one of the deadliest forms of cancer, displaying resistance to a broad range of therapeutics. Alterations of the epigenetic landscape, including aberrant histone acetylation, in both tumor and stromal cells integrate with metabolic and signaling adaptations to drive cancer cell growth, survival, and therapeutic resistance. We take pharmacological and genetic approaches to determine how targeted inhibition of Class I histone deacetylases can disrupt PDA therapeutic resistance programs in both tumor and stromal cells, leveraging these findings to sensitize PDA to existing and/or developing cancer drugs.